Helping gEnerations Identify Risks (Heirs) to Health

Project Summary
Preventive and acute healthcare are essential to ensure child health, yet, many children do not receive
adequate care. Research shows the factors associated with receipt of healthcare for children are having health
insurance coverage and/or a usual source of care and parental factors such as health conditions and health
insurance coverage. Additionally, social determinants of health (SDH) (e.g., neighborhood social deprivation,
poverty rate, food availability) are likely another burden on families' healthcare utilization, therefore, it is
important to take them into account to improve children's receipt of recommended healthcare. The parental
and/or SDH factors most strongly associated with children's receipt of recommended care are largely
unknown. Further, the pathways between and among these different factors are not clearly defined.
Additionally, it is essential to understand parents' perspectives on what prevents receipt of recommended
healthcare for their children and what they believe primary care can do to intervene. Without this information,
effective interventions to improve children's receipt of recommended healthcare cannot be devised. Therefore,
this study aims to examine the relationships between parental factors (i.e., receipt of healthcare, burden of
disease), SDH, and children's receipt of recommended healthcare. We will use comprehensive, outpatient
primary care electronic health record (EHR) data from OCHIN's (not an acronym) network of community health
centers on >2 million patients (n=354,915 children) from 18 states. In addition, we will interview about 30-40
parents to understand the factors facilitating or hindering children's receipt of recommended care. The specific
aims are: Aim 1. Identify the parental healthcare and health factors most strongly associated with children's
access to and utilization of recommended healthcare. Aim 2. Explore the influence of SDH on family
healthcare access and utilization. Aim 3. Discover additional barriers and facilitators of accessing children's
recommended healthcare and assess parental beliefs about how primary care could help them overcome
these barriers. We will employ a sequential mixed-methods approach to iteratively learn from the qualitative
interviews and conduct additional quantitative analyses based on important qualitative insights. Aims 1 and 2
identify EHR-based parental healthcare and health factors and SDH most strongly associated with children's
receipt of recommended care, while Aim 3 explores “real-life” parent perceptions of what helps or hinders
receipt of recommended care and identifies the barriers that parents believe primary care can intervene on.
The proposed work will be the first to understand the complex relationship of parental healthcare and health
factors and SDH and children's receipt of recommended healthcare and to identify the barriers that parents
believe primary care can intervene on. This formative work will propel potential interventions to improve
children's recommended care receipt. We will capitalize on unique data resources that provide information
about healthcare and health of vulnerable families.

Public health relevance
Project Narrative Many children do not receive adequate healthcare, thus it is critical to understand the reasons why not. We will use electronic health record data from OCHIN's (not an acronym) network of community health centers on >2 million patients (n=354,915 children) from 18 states and interview about 30-40 parents to understand the things that make it difficult and/or easy for children to receive recommended healthcare including exploration of parental factors and social determinants of health. This project will lead to potential interventions to improve children's receipt of recommended healthcare.